Characterization of Mucosal Lymphocytes

PROJECT SUMMARY/ABSTRACT
CD1d-restricted, invariant natural killer T cells (iNKT) cells play a critical role in regulating the commensal micro-
biota and resistance to mucosal pathogens. Conversely, iNKT cell levels are suppressed by microbiota in early
(pre-weaned), but not later (post-weaned), life. If critical microbial signals are not provided during early-life, co-
lonic iNKT cell levels remain elevated leading to increased susceptibility to colitis in later-life. Recently, we dis-
covered that colon iNKT cells are resident cells that establish themselves in early-life in a pathway controlled
locally by macrophages of fetal origin and a novel stromal cell population that is marked by Wnt4 which are in
turn regulated by the commensal microbiota. The current research proposal addresses the unanswered question
about how this newly identified stromal cell population regulates intestinal iNKT cells in early-life. Our long-term
goals are to parse out the mechanisms that microbes and the host use to establish an iNKT cell niche that
influences mucosal disease such as infection and colitis in later-life. The objective of this research is to better
understand the pathways that regulate iNKT cells in early-life as a paradigm for imprinting cellular residency
during a critical period of development. Our central hypothesis is that a unique early-life colonic stromal cell
population is part of a local tissue niche that directly imprints iNKT cells through bone morphogenic protein (BMP)
signals and determines the host’s susceptibility to inflammatory bowel disease (IBD) and enteropathogens in
later-life. Specifically, it is proposed that embryonic macrophages and microbes regulate a unique colonic stromal
cell population that is marked by Wnt4 and determines the tissue receptivity to early-life engraftment of thymic
iNKT cell emigrants through stromal cell-derived cognate (CD1d) and non-cognate (BMP2) signals. The rationale
for our proposed research is that there is very little known about early-life colonic stromal cells and their interac-
tions with immune cells. Our central hypothesis will be tested with four specific aims: 1) determine whether
colonic Wnt4+ stromal cells are an early-life specific population that forms a tissue niche with embryonic macro-
phages to support local iNKT cells; 2) Identify the specific molecules generated from colonic Wnt4+ stromal cells
that could directly support colonic iNKT proliferation during early-life and specifically the role of BMP2; 3) deter-
mine whether Wnt4+ stromal cells specifically imprint colonic iNKT cells during early-life which results in durable
effects that influence later-life disease, and; 4) determine how microbial signals regulate the cell abundance and
transcriptome of colonic Wnt4+ stromal cells during early-life. Specifically, we expect we will show that this dis-
tinctive type of stromal cell forms a tissue niche that supports iNKT cells in early-life (Aim 1) and operates through
BMP2 and CD1d expression (Aim 2) causing durable changes in iNKT cell number and function that impacts
later-life susceptibility to colitis (Aim 3) in pathways that are modulated by commensal microbes during the “win-
dow of opportunity” in early-life (Aim 4). Overall, this proposal is significant because it will define a new population
of early-life stromal cells that are potentially of fetal origin which regulate later-life susceptibility to IBD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will reveal specific details about how microbes and the host interact during a critical developmental period of early-life to determine invariant Natural Killer T (iNKT) cell levels and susceptibility or resistance to enteric diseases in later-life. Such information is of potential im- portance to diseases of the esophagus (e.g. eosinophilic esophagitis), small intestine (e.g. celiac disease) and colon (e.g. infections, cancer and inflammatory bowel disease) where iNKT cells have been shown to play a role. The proposed studies are relevant to the mission of the NIDDK because they will identify a new cell type that regulates immune cells and provide information that could be potentially used to prevent or treat mucosal dis- eases that depend upon iNKT cells.